IMPLEMENTATION OF SWIFT SEQUENCE IN 94T ANIMAL SCANNER IN PURDUE UNIVERSITY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The SWIFT sequence was successfully implemented and one invited teaching seminar about SWIFT was provided (January 2009)